Cortical Interneuron Transplantation to Treat Intractable Epilepsy.

Abstract From Original Submission
Epilepsy is a severe neurological disease affecting more than 65 million people worldwide and is characterized
by unpredictable abnormal electrical discharges resulting in recurrent seizures. About one third of patients with
epilepsy suffer from intractable seizures that do not respond to anti-seizure medications (ASMs). Neurosurgical
interventions and neurostimulator devices are useful options for only a fraction of patients with drug-refractory
seizures, underscoring the urgent need to develop new therapies. One strategy with considerable promise is to
engraft new neurons to provide enhanced GABAergic inhibition in an activity-dependent manner. However, use
of fetal neurons for cell therapy is associated with practical and ethical issues. Therefore, to overcome such
hurdles, in our previous studies, we pioneered the transplantation of human pluripotent stem cell (hPSC)-
derived medial ganglionic eminence (MGE)-type human cortical interneurons (cINs) into epileptic mouse brains
and demonstrated their integration into dysfunctional circuitry, accompanied by the suppression of seizures
and comorbid behavioral abnormalities. Furthermore, more recently, we have determined the optimal stage of
human cIN differentiation to ensure maximal integration into host circuitry as well as safety without risk of
tumor formation, and developed a method to efficiently generate these safe and highly migratory populations of
synchronized early postmitotic cINs from hPSCs in large quantities, bringing cell therapy for epilepsy one step
closer to reality. Furthermore, we have successfully tested the efficacy of human early postmitotic cINs in 2
different models of temporal lobe epilepsy (TLE), observing >80% of seizure reduction. With these strong
previous studies, now we are ready to embark clinical translation of this novel and restorative therapy for
epilepsy patients with limited options. Thus, in this proposed study, we will scale up production of synchronized
early postmitotic cINs that are optimal for grafting under cGMP condition. For added safety, we will utilize well-
characterized HLA-edited hypoimmunogenic iPSCs to minimize the need for immunosuppression for off-the-
shelf use of human cINs. We will also extensively analyze the produced early postmitotic cINs’ phenotype,
efficacy, safety, tumorigenesis and biodistribution to seek IND approval. Once we obtain IND approval, we will
do a first-in-human clinical trial of early postmitotic cIN grafting with a primary goal of safety analysis, while also
checking efficacy as a secondary measure. This will be done in patients with intractable TLE who are
candidates for resection while they undergo intracranial EEG to identify the seizure focus without additional
invasive steps. Completion of these studies is pivotal for translating this experimental therapy into a viable
therapeutic strategy for intractable epilepsy.

Public health relevance
Research Strategy Updated parts in this Supplement Application was marked in blue. There is no changes in overall specific aims in this Supplement Application, but only additional quality control testing was added as recommended by NIH- supported consultants in our LDT. A. Clinical Significance Epilepsy as a devastating neurological disorder: Epilepsy is a serious and chronic brain disorder that affects more than 70 million people worldwide19. Its fundamental characteristics include recurrent seizures and loss of consciousness caused by unpredictable and abnormal electrical discharges20. Its etiology is complicated and heterogenous, including structural, genetic, infectious, metabolic, immune and/or other unknown causes21. Currently, epilepsies are classified into focal epilepsies, generalized epilepsies, combined generalized and focal epilepsies, and unknown epilepsies based on the types of seizures the patients display21. In various etiologies and manifestations of epilepsies, more than 30% of cases are comprised of refractory epilepsies in which medical therapies fail to manage the seizures22, presenting an urgent, unmet need for new treatments. Current Treatments for Epilepsy: Anti-seizure medications (ASMs) are the mainstay of epilepsy treatments for controlling seizures23 and they are cost-effective choices for most individuals with epilepsy. However, patients responding well to ASMs typically experience adverse systemic side effects, such as skin rashes, mental slowing, visual side effects, and behavioral disorders24,25. In addition, about one-third of patients that do not respond to any ASMs have to live with intractable seizures26-29. Drug-resistant seizures can be potentially life-threatening and are associated with psychological impairments, excessive body injuries, and compromised quality of life30. Two alternatives are neurosurgical resection 31 and neurostimulation32. Compared to current drug therapies, patients that undergo surgical removal of seizure foci, are more likely to become seizure free with better quality of life33. However, surgical resection is a costly procedure, and can only be done successfully when the seizure focus can be clearly identified and safely removed without adverse impacts34. Moreover, many patients relapse after an initial seizure-free phase35. The major advantages of neurostimulation over surgical resections and ASMs are that this approach does not require removal of brain tissue, and it can be applied into a specific target region to modulate affected neural circuity32. Electrical neurostimulation is reported to be effective and acceptably safe36, but it is currently useful only in a fraction of patients with drug-refractory seizures37. Transcranial magnetic stimulation is noninvasive, but there is no powerful evidence to support its efficacy32. These limitations in the currently available treatment options for epilepsy, especially for those for refractory epilepsy, call for the development of more effective and even restorative therapeutics. Cell therapy for Epilepsy: Examination of excised epileptic tissue from patients has revealed a loss of GABAergic interneurons 38-40. Hypofunction or degeneration of cIN subsets, particularly Somatostatin (SST)+ and Parvalbumin (PV)+ cINs, are hypothesized to be key to the neural circuit dysfunction41-44 that underlies epileptogenesis. Cell-based therapeutic approaches have generated considerable interest due to their potential to increase GABA-mediated inhibition in an activity-driven manner to suppress hyperexcitable neurons during seizure initiation. Previous studies have shown that when grafted into the epileptic mouse brain, mouse fetal MGE cells (precursors of SST+ and PV+ cINs) decreased seizure activity by up to 90%45,46. However, due to the practical and ethical limitations associated with the use of fetal cells for therapeutics, we pioneered the transplantation of human developmental cINs derived from hPSCs into epileptic circuitry and demonstrated that grafted stem cell-derived human cINs migrated and integrated into hippocampal circuitry, reducing seizure frequency and ameliorating other behavioral abnormalities7,8, which was also confirmed by other labs47,48. Unlike the limited amounts of fetal cells harvested from human embryos, hPSCs can be used to generate virtually unlimited numbers of human cINs for treating neurological disorders. Cell therapy for epilepsy offers a number of advantages over existing therapies. Distinct cell types can be precisely engrafted into brain substructures 49, averting the systemic adverse effects seen with ASMs. A self-regulating therapeutic system of cIN grafts that are activated by host excitatory neurons, and in turn, release GABA at the sites of hyperexcitability 7 would eliminate the need for patients to carry devices to monitor and control seizures. Resection of the seizure focus has been used as a last-resort intervention for intractable epilepsy, but carries the risk of unwanted surgical damage to healthy neural tissues, with consequent morbidity and even permanent dysfunction 34. High-precision engraftment of cells, however, eliminates the risks of resective neurosurgery and should not only leave functional neural tissue undisturbed but also is truly restorative in nature. Table 1. Target Product Profile: Minimum Acceptable Result Ideal Result Primary Product Indication Reduction of seizure frequency for drug- refractory TLE patients Reduction of seizure frequency for epilepsy patients with clear seizure focus Patient Population Adult of all ages with drug-refractory TLE Patients of all ages with epilepsy with clear seizure focus Treatment Duration One-time cell delivery that results in long- term seizure control One-time cell delivery that results in long- term seizure control Delivery Mode Stereotaxic injection into seizure focus Stereotaxic injection into seizure focus Dosage form Cryopreserved Cells Cryopreserved Cells Regimen One time One time Efficacy 50% or more reduction of seizure frequency compared to pre-treatment using EEG analysis in 50% of patients 50% or more reduction of seizure frequency compared to pre-treatment using EEG analysis Risk/Side Effect Devoid of symptomatic intracranial hemorrhage, tumor formation and significant CNS side effects Devoid of any symptomatic intracranial hemorrhage, any tumor formation and any CNS side effects Therapeutic modality hypoimmunogenic Cells hypoimmunogenic Cells For the primary product indication, the minimum acceptable criteria could be efficacy for drug-refractory TLE patients, where we have extensive animal model data, but later this could be expanded to other patients with epilepsy as long as clear seizure focus can be identified. For patient populations, adults of all ages with drug-refractory TLE will be selected as the minimum acceptable population again based on our extensive previous data. Down the road, this can be expanded to patients of all ages with epilepsy with clear seizure foci. Treatment will be a one-time stereotactic injection of cell suspension into the seizure focus that results in long- lasting seizure control. Based on the studies in animal models, ideal efficacy would be >50% reduction of seizure frequency compared to pre-treatment using EEG analysis, but the minimally acceptable will be 50% or more reduction of seizure frequency compared to pre-treatment using EEG analysis in 50% of patients until dose is fully optimized through clinical trials. Ideally there won’t be any symptomatic intracranial hemorrhages based on high accuracy targeting employing robotic navigation system, nor will there be any tumor formation based on the use of only postmitotic neurons. In addition, there will not be any CNS side effects based on the study in model animal where host inhibition was saturated with low graft cell densities (Fig. 6). Clinical Trial of early postmitotic cIN transplantation for Epilepsy: Once we obtain IND approval, we can graft cGMP quality human early postmitotic cINs that will be generated via this proposed study for a small number of patients as a first-in-human clinical trials. We will focus on TLE patients with intractable seizures as the initial target, considering many of them who are candidates for resection go through invasive EEG analysis, during which the cells can be delivered without additional invasive steps. The fact that they do not respond to ASMs further justify the clinical trial on this cohort. There are usually enough patients who are candidates for resection in given year, so we expect to be able to recruit patients for this clinical trial without any problem. In the unlikely situation in which unexpected graft-related adverse impact is observed, the patients can undergo resection as in the original recommendation, which will remove the graft without any additional invasive procedure. Clinical trials will be done at WMC, the affiliated hospital of NYMC. Dr. Carrie Muh, a neurosurgeon at WMC/NYMC has extensive experience with various stereotaxic neurosurgical procedures including intracranial EEGs, and human cINs will be implanted using the same stereotactic navigation system (ROSA ONE Brain robot) as used for these procedures but with cannula. The primary outcome will be the safety of human migratory cIN grafts but the patients will be also monitored for efficacy by EEG as a secondary measure. In addition to Dr. Muh, we have a team of epileptologists and a clinical psychologist at BCH/WMC/NYMC on board who will assess the patients for any safety issues and efficacy. Our clinical team will also be actively involved in biotherapeutic development program and clinical trial designs. This first-in-human trial will allow us not only to confirm the safety of human migratory cIN grafting but also to assess their efficacy, providing needed information to design further clinical trials in the next phase. B. Significance: Biological rationale Generation of MGE-type cINs from human PSCs 50: Based on developmental studies, we optimized derivation of MGE progenitors during hPSC differentiation by modulating developmentally relevant signaling pathways (SHH, Wnt and FGF8) as summarized in Fig. 1a. Under our optimized protocol, we can generate highly homogeneous populations of MGE cells expressing Nkx2.1, FoxG1 and Olig2 (Fig. 1b-f). When further differentiated, human MGE cells spontaneously generated cINs that express Lhx651, GAD and Sox6, which is a very specific human MGE-lineage cIN marker52 (Fig. 1g-k). Our technology is based on generation and use of these Sox6+ MGE-type cINs and is protected by 2 patent applications previously filed as detailed in Other Attachments section. Homogeneity of generated cell population will ensure we obtain reliable products for clinical use. Functional efficacy of hPSC-derived cINs in treating epilepsy: hPSC-derived cINs were further characterized after grafting into NSG mice brains. When analyzed by iDISCO+ clearing, light sheet microscopy and Imaris analysis, grafted developmental cINs extensively migrated even in the adult brain reaching a 3,500µm span of cortex analyzed (Fig. 2a-c), just as they extensively migrate during normal embryonic development. As grafts mature, a small portion of human cINs start to express MGE lineage cIN subtype markers, SST and PV (Fig. 2d), in line with their protracted in vivo developmental timeline53 where mature subtype markers such as PV mostly start to be expressed postnatally54. Furthermore, integration of grafted cells efficiently reduces seizure in PILO-TLE model in mice7 (Fig. 3a). They also ameliorated comorbid cognitive deficits as analyzed by Y-maze and Novel object recognition test (NORT) 4 months post grafting7 (Fig. 3b-c), demonstrating the efficacy of stereotactically delivered human cINs for treating epilepsy and its comorbidity. EEG analysis with N=11 achieves 99% power to reject null hypothesis of equal means when the population mean difference is 1.5 with a standard deviation of 0.7 and with a significance level of 0.05. The mice with >15,000 surviving human nuclei+ grafted cells were included for behavioral analysis and one mouse was excluded according to these criteria. Generated PILO- TLE models were randomly assigned to different groups for experiments. All behavior analysis was done blindly without knowledge of group designation from experimenters. After long- term grafting of 9 months, graft cells robustly maintained anti-epileptic efficacy without detectable proliferation8 (Fig. 3d). One time stereotaxic cell delivery that resulted in sustained anti-epileptic efficacy without uncontrolled growth after long term grafting gives us confidence that this scheme will result in well-integrated cIN grafts with sustained efficacy in the patients. We also tested the efficacy of human cINs in yet another model, KA-TLE model in NSG mice. These mice develop granule cell dispersion, cell death and microglial activation in the hippocampus8 (Fig. 4a), well-recapitulating hippocampal sclerosis in human TLE patients, the most common cause of drug-resistant epilepsy. They develop frequent and consistent focal seizures (>20 seizures per day), which allows for a much shorter monitoring period to obtain reliable results (Fig. 4b), compared to PILO-TLE model in mice with sparser and often generalized seizures. Grafted human cINs also reduced seizure frequency >80% (Fig. 4b) in KA-TLE mice and also ameliorated cognitive deficits as analyzed by NORT8 (Fig. 4c). Robust efficacies of human cINs in ameliorating seizure and comorbid cognitive deficits, as replicated in 2 independent animal models, allow us to move onto clinical translation with confidence. To understand the basis of observed efficacy, we extensively analyzed synaptic integration and functionality of human PSC-derived cIN graft using electrophysiological approaches7,9 (Fig. 5). More than 80% of grafted human cINs show spontaneous AP firing (Fig. 5d) in the grafts and receive excitatory input from host glutamatergic neurons (Fig. 5e), demonstrating their functional integration into host circuitry. Graft-induced inhibition of host neurons after stereotaxic cell delivery was optogenetically analyzed (Fig. 5f-i), employing human cIN grafts derived from 2 different iPSCs. The majority of host neurons patched showed optogenetic light-induced inhibitory postsynaptic currents (oIPSCs; Fig.5i), demonstrating efficient inhibition of host neurons by grafted human cINs and provide the mechanistic basis of their efficacy by inhibiting hyperexcitable epileptic circuitry. We also observed a significant increase in host spontaneous inhibitory postsynaptic currents (sIPSCs) by grafted cINs (Fig. 6a), again providing mechanisms for their efficacy. When correlated with grafted cell density analyzed by 3D imaging (Fig. 6b), host inhibition did not continue to increase with increasing graft cell densities but was saturated at relatively low densities (Fig. 6c). This result suggests that high dose of cIN grafts won’t result in over- inhibition-related side effects (e.g. somnolence). Identification of the optimal stage of human developmental cINs for efficient grafting18: With the purpose of moving this promising therapeutic to the clinic, we have identified the developmental stage of human cINs that is optimal for cell transplantation, and developed a method to generate these optimal cell populations in large quantities using bioreactor-like spinner culture methods and extensively characterized them18, readying this promising therapeutic for clinical translation. hPSC differentiation is an asynchronous process just as during embryonic development, generating a mixture of proliferating progenies and postmitotic neurons at the same time. The presence of proliferating cells causes safety concerns with the possibility of uncontrolled growth. Thus, we identified chemicals that can direct human MGE cells into postmitotic cINs and treated them with the mixture of efficacious chemicals (CDP: CultureOne (Invitrogen) + DAPT + PD0332991; Fig. 7a-c). While this treatment significantly reduced proliferating cells among the progenies, they still maintained the MGE-type cIN phenotype (Fig. 7d-e). Chemically induced maturation of cINs resulted in enhanced migration of treated cells (Fig. 8). This is an important property for maximal integration into the host circuitry, considering that cINs lack long-range projection, but rather need to physically migrate throughout large areas of human epileptic circuitry to form local synaptic connections. We have previously shown that one of the key features of cIN maturation is their increase in metabolic function to meet the larger energy demands of mature cINs 18 and chemically induced maturation also resulted in enhanced metabolism, as analyzed by a Seahorse analyzer (Fig. 9a). Furthermore, CDP- treated neurons showed enhanced arborization (Fig. 9b), as well as more mature electrophysiological properties (Fig. 9c), suggesting that CDP-treated cINs are in a better position to efficiently integrate into the host brains and regulate aberrant epileptic circuitry. We further characterized chemically matured cINs after transplantation into NSG mouse brains. Treated cells display MGE-derived cIN phenotypes in vivo, expressing GABA and Sox6 (Fig. 10a-b) and showed enhanced migration in host brains even at 1 month after grafting, at which time point there is not much migration observed in control grafts (Fig. 7c-d). Furthermore, whereas about 4% of control grafted cells were still proliferating 1 month after grafting, CDP-treated grafts were rarely proliferating (Fig. 10c and e), ensuring safety of graft without uncontrolled growth. Furthermore, CDP-treated cells formed significantly more synaptic connections in the host brains compared to the untreated cells (Fig. 10f). Four mounths after grafting, CDP-treated cells had extensively migrated into the host hippocampus (Fig. 11a), leaving only a negligible graft core (as defined by >13 grafted cells in 75µm x 75µm counting frames), as analyzed by stereological analysis (Fig. 11b). Their integration was also accompanied by seizure reduction (Fig. 11c), even in neuroninflammatory epileptic brain environments (Fig. 11d). So far, we have used chemically matured cINs from multiple different hPSCs, including human ESCs and human iPSCs, all with similar efficacies. Together these results demonstrate the advantage of our key patented technology-using CDP-treated synchronized early postmitotic cINs for cell therapy for epilepsy, with better integration into the host circuitry as well as with no detectable proliferating cells that ensure long- term safety of the graft without potential tumor growth. Table 2. Target Agent Profile: Category Parameters Structure/Identity Human iPSC-derived early postmitotic cINs with >70% Sox6+, <5% Pax6+, <0.2% Nanog+, as analyzed by flow cytometry. In vitro activity Extensively migrate when seeded on Matrigel substrate, and release GABA. Target tissue/Cell biodistribution and expression/tropism Human cINs distribute within the grafted brain structures (e.g. hippocampus) but not in non-grafted brain areas. In short term, they cluster together in injection site and over time they extensively migrate within grafted brain structure. In vivo activity. Indicate dose and route of administration When stereotactically delivered into the seizure focus, human cINs migrate in the host brains and make synapse connections with the host neurons and inhibit hyperexcitable host epileptic circuitry. Restoration of normal inhibition by grafted human cINs also results in amelioration of cognitive deficits in TLE model animals. Our graft density-host inhibition analysis showed that the inhibition reaches plateau at low graft densities. Safety TLE model animals well tolerate stereotactically delivered human cIN grafts and are healthy. Due to use of postmitotic neurons, we do not observe uncontrolled growth in the grafts. Grafted cINs did not change the neuroinflammatory phenotype of TLE brains (Fig. 11d). We will use HLA-edited hypoimmunogenic iPSCs to minimize the need for immunosuppression and related confounders. Saturation of host inhibition at low graft densities suggest that high doses of cIN grafts won’t results in over-inhibition- related side effects (e.g. somnolence). We don’t expect adverse interaction between grafted neurons and standard care, but will carefully monitor during safety clinical trial. CMC Previously, we developed a method to generate migratory human cINs on a large scale. Also, all the reagents have cGMP-compatible counterparts, and thus, the PI’s lab will test them first and transfer fully cGMP-compatible technology to CRO for large scale cGMP production. Generated cGMP-quality human cINs will be frozen down for QC, IND-enabling studies and clinical trials. Cryopreserved cells are stable for an extended period of time, when stored in a liquid nitrogen dewar. >70% Sox6+, <5% Pax6+, <0.2% Nanog+ and no QC abnormalities (sterility, endotoxin, karyotyping, oncogenic mutation) as well as >70% viability upon thawing will be used as release criteria. Cells will be delivered via stereotactic injection as done in preclinical studies. GLP analytical method development/validation Toxicology and biodistribution studies will be done at NIH CRO under good laboratory practice (GLP) conditions. Since efficacy testing cannot be done in CRO due to their limitation in generating animal models of epilepsy, it will be done in PI’s lab under near GLP condition, as in another cell therapy IND approval12. Regulatory agencies INTERACT meeting was completed in April of 2022 (see Appendix for summary). Patent protection There are 2 related Patents filed by the McLean Hospital and NYMC, one on derivation of iPSC-derived human Sox6+ cINs to treat epilepsy and the other on large scale generation of human cINs optimal for grafting in terms of host integration and safety. Overall, our strong previous studies that include the optimization of human cIN generation for cell therapy, their long-term safety as well as a mechanistic understanding of their efficacy have uniquely positioned us to successfully translate these experimental therapeutics into viable human therapies. C. Approach Our goal is to develop human cIN transplantation as a viable treatment for intractable epilepsy. In the proposed study, we will enter at UG3 Development Preparatory phase comprised of scaling up of production with cGMP- compatible components and pre-IND meeting, followed by extensive UH3 Development phase including large scale cGMP production, QC of generated cells, efficacy/safety/biodistribution analysis, and clinical trials once we secure IND approval. Proposed project is summarized in the Table 3 and Fig. 15. The aim of this supplement is to support additional GLP testing of the master cell bank as recommended from NIH-funded consultants on our Lead Development Team. LDT consultants recommended GLP testing of the master cell bank, including Karyotyping, STR analysis, Mycoplasma testing, in vitro & in vivo adventitious analysis and TEM analysis. We already covered multiple cost increases in GMP production and personnel, and thus our current budget cannot cover these additional items. Furthermore, the high cost of GLP testing makes it impossible to cover by rebudgeting. There are no matching institutional funds available to carry out additional GLP testing recommended by the FDA. Additional QC measures supported by this supplement will facilitate the IND approval from the FDA, considering the FDA’s previous recommendation to include GLP adventitious agent testing for the master cell bank. Currently, iPSC tech transfer run has been completed, and will initiate Master Cell Bank generation this month (May of 2025). Thus, we expect to be able to do needed quality control assays starting sometime in Jun of 2025. We expect the support from this Supplement will help ensure generate strong pre-IND and IND packages, fully complying with current requirement from FDA. Table 3. Table of proposed activities and timeline: Activity Source Go/No-Go Criteria Timeline of proposed activity scale up with cGMP reagents PI lab Generation of >70% Sox6+ cINs, <5% Pax6+,<0.2% Oct4+ Yr 1 mo 1 - 6 Pre-IND meeting LDT/PI lab Feedback from FDA Yr 1 mo 1 - 6 cGMP production- technology transfer/test run Fee for service CRO/PI lab Generation of >70% Sox6+ cINs, <5% Pax6+,<0.2% Oct4+ Yr 1 mo 7 - 12 cGMP production-large scale production and QC Fee for service CRO/PI lab Pass described release criteria (QC, viability, and phenotypes) Yr 2 mo 1 - Yr 3 mo 6 Efficacy testing of cGMP quality cINs PI lab >50% seizure reduction Yr 2 mo 7 - Yr 3 mo 12 Toxicology/safety NIH CRO No treatment-related toxicity Yr 3 mo 1 - Yr 4 mo 6 Tumorigenesis NIH CRO No tumor formation Yr 3 mo 1 - Yr 4 mo 6 Biodistribution NIH CRO No distribution outside CNS Yr 3 mo 1 - Yr 4 mo 6 IND application/Regulatory documents preparation LDT/CDT/PI lab IND approval/IRB approval Yr 4 mo 1 - 12 First in human clinical trial WMC/BCH/PI lab No treatment-related adverse effect Yr 5 mo 1 - 12 Aim 1. Large scale production of human early postmitotic cINs under cGMP conditions: Based on our previous study where we optimized large scale cell production using the spinner culture method18, we will scale up human early postmitotic cIN production but using cGMP-quality components. For added safety, we will use HLA-edited hypoimmunogenic iPSCs1 to minimize the need of immunosuppression for off-the-shelf use. Once we optimize a large-scale culture using cGMP reagents, cINs will be generated in a cGMP facility and frozen down for QC, IND-enabling studies and clinical trials. NIH cGMP cell production CRO is not available yet at the time of this application, and thus we will use cGMP facility at cGMP Advanced Cell and Biologic Product Manufacturing Core Facility at University of Miami (See the letter of support). In addition, we will set up LDT’s pre-IND meeting with the FDA during this initial phase to fine-tune each Aim based on FDA feedback. Experiment 1: Scaling up differentiation using cGMP-compatible reagents: Hypoimmunogenic iPSCs, with HLA-A, HLA-B and CIITA knock out (KO) to minimize HLA-mismatch but with intact HLA-C and HLA-E expression to prevent NK cell-mediated killing1, were obtained from CiRA in Japan to minimize immunosuppression for the patients. These cells were 1) proven for their hypoimmune properties (e.g. inability to stimulate human CD8+ T cells in vitro and in vivo1,2), 2) thoroughly characterized for clinical use at CiRA (sterility, endotoxin, STR, karyotyping and whole exome sequencing without known Cancer gene mutations) and 3) meet the donor eligibility criteria and will go into clinical trial for PD in the US as in INTERACT summary. HLA-edited iPSCs will be expanded using cGMP-compatible reagents (Essential 8 media and rLaminin-521 as substrates) at cGMP Facility at University of Miami to generate initial clinical grade iPSCs banks (40 vials of 2 million cells per vial) with full QCs (sterility, mycoplasma, endotoxin, STR genotyping, Karyotyping, whole exome sequencing and viability testing) at CRO as well as flow cytometry confirmation of hPSC marker expression (Tra1-60 and Oct4) in the PI’s lab. Previously, we optimized human cIN production using bioreactor-like spinner culture18, and we will generate cINs using the same published protocol18 but with cGMP- compatible reagents. All the components used for our cIN derivation protocol18 have available cGMP- compatible alternatives and thus we will test and optimize each component individually and then together for the transition into cGMP production. Human cINs that are generated using cGMP-compatible reagents in the lab will be verified as below. Experiment 2: phenotype analysis on produced human early postmitotic cINs: Phenotypes of generated cINs will be analyzed by immunocytochemistry and flow cytometry using various antibodies as follows: cortical interneuron markers (GABA, GAD1, PV, SST, Calr, NPY), non-interneuron neural subtype markers (GFAT, O4, Pax6, TH, 5HT, ChAT, vGlut1) and proliferating cell markers (Ki67)/pluripotency markers (Tra1-60 and Oct4) to assess safety and potential for tumorigenesis. Total cINs (GAD1+), different subtypes (PV+, SST+, Calr+, VIP+), and total proliferating cells (Ki67+) are quantified using the StereoInvestigator system (MBF bioscience) and flow cytometry. All these analyses are well-verified from our previous studies (Fig. 1)7,9,50. Experiment 3: Large scale production of human early postmitotic cINs under cGMP condition: Once replacing with cGMP-compatible counterparts is completed, we will transfer technology to the CRO facility for initial small scale test run spinner culture (50ml scale) under cGMP conditions, followed by phenotype analysis at PI’s lab as above. Once we confirm the good phenotype (>70% Sox6+ cINs, <5% Pax6+, <0.2% Oct4+), large scale differentiation will be done with 500ml spinner at cGMP CRO facility and frozen down using cGMP cell freezing media (Stem Cell Technologies) for QC (sterility, mycoplasma, endotoxin, STR genotyping, Karyotyping, whole exome sequencing and viability testing) at CRO site as in the letter of support and phenotype analysis in PI’s lab as described above. In this supplement, we are adding additional GLP testing of the master cell bank as recommended by NIH-funded consultants on our Lead Development Team. LDT consultants recommended GLP testing of the master cell bank, including Karyotyping, STR analysis, Mycoplasma testing, in vitro & in vivo adventitious analysis and TEM analysis. Among these testing, Karyotyping, STR analysis and Mycoplasma testing was originally proposed as research grade non-GLP, but we were recommended to use GLP grade testing. Adventitious agent testing was not included in the original proposal, but was added in consultation with LDT clinical consultant. These added GLP testing, as recommended by LDT consultants, will facilitate IND approval from the FDA. Based on smaller spinner cultures (50ml media) done in the PI’s lab, we expect to obtain at least 500 million cells from a 500ml culture and be able to generate 50 stocks with 10 million hypoimmunogenic human early postmitotic cINs per vial from one 500ml culture. We will do 3 large productions in 3 batches rather than a single bigger batch to safeguard against the unlikely case scenario where one of the differentiations is suboptimal, though we have successful generated cINs using spinner cultures from >30 different iPSCs. The batches that passed QC without any abnormalities and with robust phenotype induction will be used for IND-enabling studies and later clinical trials. Based on our previous studies, we will use the following release criteria: 1) no abnormalities in QCs, 2) >70% viability upon thawing and 3) >70% Sox6+ cINs, <0.2% iPSCs (Oct4+, Tra1-60+) and <5% Pax6+ progenitors in phenotype by flow cytometry analysis. Potential pitfalls and alternate approaches: Based on our extensive experience in stem cell differentiation and histological analysis, we do not anticipate any major problem. Furthermore, >30 iPSC lines we have utilized can be efficiently differentiated into cINs using our published protocol18 (our preliminary data and previous publications8,9,55), further strengthen the feasibility and reproducibility of our protocol. In the unlikely situation that an iPSC batch displays inefficient differentiation into cINs, we can remove that batch and replace them with another batch/line that shows more authentic pluripotency and can be directed by relevant extrinsic signals. We have received multiple vials of 4 different HLA-edited iPSC lines from CiRA and the CiRA repository continues to develop edited iPSC lines, so there won’t be a problem in replacing with another line or batch. CiRA provides HLA-...